Training Program in Hearing and Balance

? DESCRIPTION (provided by applicant): The proposed Training Program in Hearing and Balance will provide research training to predoctoral and postdoctoral students in the Center for Hearing and Balance. The training focuses on research on the normal and damaged auditory and vestibular systems. Research approaches include neurophysiology, human and animal behavior, theoretical and computational methods, neuroanatomy, molecular biology, genetics, and cellular physiology. The objective is to provide a multi-disciplinary program in which trainees from diverse backgrounds can gain experience with a range of methods. The training faculty are drawn from the Departments of Biomedical Engineering, Electrical and Computer Engineering, Neurology, Neuroscience, and Otolaryngology-Head and Neck Surgery at the Johns Hopkins University. The trainees will include five predoctoral students recruited from the graduate programs of Biomedical Engineering or Neuroscience and five postdoctoral fellows with appropriate doctoral degrees recruited directly to the program and appointed in one of the participating departments. At all levels, training will focus on research, taking advantage of the excellent research facilities available in the Center. Trainees participate in the weekly research seminar of the Center as well as one of the available journal clubs. The program provides a year-long core course in Hearing and Balance and specialty courses in molecular, cellular, and systems biology and in computation and theory. Predoctoral trainees generally participate for up to five years and postdoctoral trainees for two to three years.

Public health relevance
PUBLIC HEALTH RELEVANCE: Disruption of hearing or balance can have severely negative effects on the quality, and quantity of life. There is a need for new researchers trained in the most modern methods and advanced theories to provide new diagnostic tools and therapies to ameliorate these conditions. The training program of the Center for Hearing and Balance is aimed at providing the innovative scientists who will meet this need.